Analysis Core

ANALYSIS CORE ABSTRACT
By virtually any measure, elderly American Indians, Alaska Natives, (AI/ANs) and Native Hawaiian and Pacific
Islanders (NHPIs) are at higher risk than elderly non-Hispanic Whites for numerous acute and chronic illnesses.
As displaced Indigenous people, they are affected by certain social determinants of health that present
intractable barriers to health equity. In 2021 life expectancy for AI/ANs (72 years) was lower than for Blacks (75
years), Whites (79 years), and Hispanics (82 years). In the same year, the National Center for Health Statistics
noted that life expectancy could not be estimated for NHPIs due to unreliable death certificate data. A diverse
scientific workforce enhances the quality and impact of public health research with underserved populations, and
for many years the NIH has sponsored programs aimed at increasing the number of underrepresented minority
Principal Investigators in its ranks. However, AI/AN and NHPI Principal Investigators continue to account for a
miniscule fraction of academic health research faculty, and in the higher ranks (e.g., Full Professor and
administrative leadership) they are nearly nonexistent. The Community Health and Aging in Native Groups
of Elders (CHANGE) Resource Center for Minority Aging Research (RCMAR) is a continuation of the Native
Elder Research Center RCMAR. Its goals are to recruit, train, and nurture a highly diverse cadre of early-stage
investigators, referred to as CHANGE Scientists, who are pursuing careers dedicated to Native aging and Native
Elders’ health research. The program will recruit 3 Scientists in each of 3 cohorts (9 total). Cohorts progress
together through an 18-month curriculum comprising a 12-month Pilot Study and a 6-month grant writing
program. The CHANGE Analysis Core’s Specific Aims are to: 1) offer state-of-the-art support research
methods support to optimize the study design, measurement, data quality, and scientific validity of data analysis
for CHANGE Pilot Studies; 2) provide mentoring, deliver didactic instruction, facilitate networking, and support
grant writing for CHANGE Scientists; 3) demonstrate applied principles of community-based participatory
research by adopting our novel 5-step rubric for quantitative methodologists; and 4) analyze program evaluation
data collected by the Leadership and Administrative Core and by the Research and Education Component,
catalog and disseminate CHANGE products, and collaborate with the RCMAR Coordinating Center to optimize
the RCMAR initiative’s impact. The Analysis Core team offers expertise in epidemiology, biostatistics,
demography, and qualitative research methods. Core Faculty have many years of experience providing
quantitative and qualitative methods support for Native health research studies led by AI/AN and NHPI Principal
Investigators in collaboration with community partners, and they have a strong track record of mentoring Native
and other underrepresented minority early-stage investigators, including RCMAR Scientists. The Analysis Core
will work to ensure that CHANGE Pilot Studies yield accurate, reliable data; and to promote CHANGE Scientists’
professional development and NIH-funding success.